Training the Science of Child Mental Health Treatment

Project Abstract
This competitive continuation proposal requests renewal of our postdoctoral Ruth L. Kirschstein National
Research Service Award Institutional Research Training Program (T32) at UCLA, entitled “Research Training:
The Science of Child Mental Health Treatment”, 5 T32 MH073517-14 for 5 years for funding to recruit 3 new
postdoctoral fellows per year for a two-year mentored training experience (total 6 trainees per year). No
predoctoral trainees are proposed. The unique focus of this training program is on training researchers in
clinical translational intervention science for child mental disorders to prepare them to become independent
transdisciplinary investigators. Trainees will identify specific domains of mental illness and chose research
strategies that advance such research at a variety of levels—treatment mechanisms, biomarkers, efficacy
study methodology, and implementation science, touching on a large number of Objectives as outlined in the
NIMH Strategic Plan. General goals for the trainees will be to obtain a broad background in current issues in
child mental health treatment research; develop expertise in a scientific method for application to studies of
child treatment; complete significant independent research in a designated area of research; and develop skills
necessary for transitioning into an independent investigator. The program has been very successful, with the
majority of graduates retained and advancing in research, and some 50% of funded trainees coming from
under-represented minority backgrounds.
Research training in this renewal will sharpen the program’s focus on clinical research, examining
disorder-related areas from a transdiagnostic framework—disruptive/impulsive/compulsive behaviors, autism
and neurodevelopmental disorders, pediatric emotional disorders including self-harm, and other
neuropsychiatric disorders. New emphases include training in “big data” science and research on mental
health disparities. The core training experience will occur within the trainee’s own research and in their close
interaction with primary and secondary mentors and preceptors, and the weekly T32 core seminar. In addition,
participation in individually tailored didactic coursework across the UCLA campus, training in the responsible
conduct of research, and supplementary coursework and experiences will provide broad and specific
knowledge in research approaches.
The proposal consists of recruiting 3 new postdoctoral fellows/year with medical or doctoral degrees for
a 2-year experience. Postdoctoral trainees will possess training in a discipline relevant to human research and
child mental health treatment. The program will benefit from the breadth of active child treatment research at
UCLA and from the supplemental training available from a wide variety of departments, programs, research
units, and other training activities.

Public health relevance
Project Narrative This proposal requests competitive continuation funding for renewal of a postdoctoral Ruth L. Kirschstein National Research Service Award Institutional Research Training Program (T32) at UCLA for 5 years for the funding of 6 postdoctoral positions per year. The focus of the training program is on training researchers in the area of clinical translational intervention science for child mental disorders to prepare them to become independent transdisciplinary investigators. During the 2-year training period, postdoctoral researchers will mentored independent research under the mentorship of a primary and secondary mentor, develop core competencies for clinical research, receive formal didactic and experiential training in a designated area of research, as well as training in ethical issues in research and the responsible conduct of research involving children and families.